Counseling for Harm Reduction and Retention in Medication-assisted treatment - Cherokee Nation (CHaRRM-CN)

ABSTRACT
American Indian (AI) people are disproportionately impacted by opioid use disorder (OUD) and its related harm.
From 2019 to 2020, there was a 39% increase in overdose mortality rates for American Indian/Alaska Native
(AI/ANs) people compared to 22% for white people. As evinced by the current OUD milieu, opioid-related
disparities are amplified among AI people. Fortunately, medication-assisted treatment (MAT) is highly efficacious
in reducing overdose and opioid-related harm. Despite being the gold-standard of OUD treatment, MAT’s efficacy
is contingent on treatment retention. A systematic review found a median retention rate of 56% at the 12-month
treatment period. This is concerning due to treatment retention being associated with reduced mortality rates
within OUD. In addition, there are no studies to date that have analyzed the effectiveness of MAT in AI
communities. Despite the dearth of literature, research has indicated that gathering insight from those who are
affected by OUD is critical to improving substance-use treatment. Correspondingly, a new NIH-funded CBPR
research project entitled, “Counseling for Harm Reduction and Retention in MAT in Cherokee Nation” (CHaRRM-
CN; R61/R33DA049376; PIs: Nelson, Collins, Taylor), is engaging the largest tribally run MAT program in the
US to collaboratively improve MAT for AI people with OUD. In the prior R61 phase, results were presented to a
community advisory board and used to codevelop a lower-barrier, more culturally aligned and community-driven
approach to MAT. The resulting CHaRRM-CN components include: harm-reduction and culturally aligned
counseling, lower-barrier MAT service provision, monitoring of participant charts, and increasing connection to
community-based cultural events. The current R33 phase of this project will assess the effectiveness of the
resulting components in improving MAT retention, substance-related harm, and illicit opioid use. The subsequent
diversity supplement will expand upon this work. Emma Shinagawa is a second-year clinical psychology
graduate student whose career goal is to work collaboratively with people who use substances and other
community stakeholders to develop and disseminate evidence-based interventions as an independent
researcher. The supplement she proposes titled Perceptions and Relative Contributions of Components in the
Context of the Counseling for Harm Reduction and Retention in MAT with Cherokee Nation (CHaRRM-CN)
Treatment for American Indian Medication Assisted Treatment (MAT) Patients with Opioid Use Disorder (OUD)
will track the R33 CHaRRM-CN arm participants’ (N=80) engagement with various intervention components and
evaluate whether overall engagement to CHaRRM-CN components and/or specific CHaRRM-CN components
is associated with positive treatment outcomes. The primary treatment outcome is MAT retention with secondary
outcomes being cultural connectedness, substance-related harm and illicit opioid-use This supplement will
facilitate Ms. Shinagawa’s development into an independent investigator and will build upon her prior experience
working with communities impacted by substance use.

Public health relevance
PROJECT NARRATIVE The diversity supplement will highlight the perceptions and relative contributions of components in the context of the Counseling for Harm Reduction and Retention in MAT with Cherokee Nation (CHaRRM-CN) treatment for AI MAT patients with opioid use disorder (OUD). This supplement is well positioned to assess the relative contribution of a multicomponent treatment approach to thus increase MAT retention, reduce illicit opioid use and substance-related harm, and increase cultural connectedness and health-related quality of life. This supplement may have broader implications on increasing accessibility to more culturally appropriate and community-driven interventions.